Preventing Suicide in African American Adolescents

Abstract
The aim of this grant application is to test the effectiveness of a culturally-adapted, school-
based suicide prevention intervention, delivered by indigenous Rush University social workers
(i.e., “intervention social workers”), for low-resourced, urban, African American 9th grade
students. Rates of suicide among African American youth have increased substantially in the
past 20 years, and suicide is currently one of the leading causes of death among African
American adolescents. As such, there is a need for effective, sustainable prevention
interventions for these populations. Our study will train intervention social workers to deliver a
culturally-adapted, evidence-based coping with stress prevention intervention (i.e., the
Adolescent Coping with Stress Course [A-CWS]). Urban African American adolescents who
have participated in the A-CWS have demonstrated decreases in suicide risk, as well as
decreases in anxiety and increases in several dimensions of adaptive coping (i.e., use of
positive coping strategies for problem experiences, positive thinking, depression coping self-
efficacy). We aim to demonstrate that indigenous intervention social workers can implement the
A-CWS with fidelity and that participants in intervention groups facilitated by indigenous
intervention social workers experience increases in levels of adaptive coping. We will examine
the extent that interpersonal factors (i.e., thwarted belongingness, perceived burdensomeness)
and socio-ecological factors (i.e., community violence exposure, limited neighborhood
resources, family dynamics) influence active suicidal ideation. We will test whether these factors
influence active suicidal ideation in African American adolescents. Lastly, our study will examine
the mechanism by which the A-CWS intervention reduces suicide risk for low-resourced, urban
African American adolescents. We will examine the ability of adaptive coping skills, gained
through participation in the A-CWS intervention, increase hope and reduce hopelessness. We
will then examine the moderating effects of hope and hopelessness on the influence of
interpersonal and socio-ecological factors on active suicidal ideation. This translational study
has public health implications. It will expand the understanding of mechanisms of change
related to suicide risk reduction in urban African American adolescents. It will test a modified
version of the Interpersonal Theory of Suicide for urban African American adolescents. Lastly,
our study will inform the training and monitoring of indigenous mental health professionals to
deliver evidence-based prevention interventions for urban African American adolescents; as
such, our study will inform the practice of prevention intervention sustainability and
dissemination.

Public health relevance
To examine the effectiveness of an evidence-based and culturally-grounded stress-reduction intervention (i.e., the A-CWS), facilitated by indigenous social workers, to increase adaptive coping and reduce active suicidal ideation in African American 9th graders. This study has broad public health implications and informs procedures for scaling up efficacious, high quality, and culturally grounded suicide prevention programs and best practices for the prevention of suicide among African American adolescents.